RAPID ACCELERATION OF DIAGNOSTICS (RADX) CLINICAL EVALUATION SERVICES -TASK ORDER 06

The National Institutes of Health (NIH) Rapid Acceleration of Diagnostics (RADx®) Tech program was established to accelerate regulatory review and availability of high-quality, accurate, and reliable diagnostic tests. This project generated evidence to support regulatory filings with the US FDA to attain Emergency Use Authorizations for 2 over-the-counter SARS-CoV-2 diagnostic products.